Cytopathology Core

Cytopathology provides diagnostic evaluation of cytology specimens that direct patient management and treatment. The Cytopathology Section provides complete diagnostic service in cytopathology for the various clinical protocols at the NIH. We specialize in the application of ancillary techniques (i.e., immunocytochemistry, flow cytometry and molecular testing) to patient material for the confirmation of morphologic diagnoses, evaluation for protocol entry criteria and collaborative investigations. The Cytopathology Section evaluates cytology specimens from the central nervous system, pleural/peritoneal/pericardial cavities, respiratory tract, genitourinary tract, gynecologic system, fine needle aspiration (FNA) samples of various organs, and other less common cytology specimens. Due to the nature of the specimen material evaluated by our Section, often our cases require immunocytochemical and/or other ancillary studies. The immunosuppressed nature of our patient population at the NIH dictates that a significant proportion of our cases require special studies for pathologic organisms. The relatively high rate of pathologic findings combined with the diversity of types of exfoliative and FNA specimens provide a broad experience in diagnostic cytopathology for anatomic pathology residency and cytopathology fellowship training. The Cytopathology Section is involved in numerous clinically related research studies, many of which utilize FNA or non-gynecologic exfoliative samples with immunocytochemistry and/or molecular techniques to provide additional ancillary diagnostic, prognostic, therapeutic or protocol required information. A partial list of such studies includes: (1) cytomorphologic and immunocytochemical evaluation of tumor infiltrating lymphocytes samples for possible tumor cell contamination prior to therapy; (2) FNA material for subsequent analysis by molecular technologies; (3) application of RNA-based molecular technique to non-gynecologic and FNA cytology samples to enhance diagnosis, prognosis and patient management; and (4) cytomorphologic evaluation of oral mucosa brush biopsy samples for possible dysplasia or cancer.